EFFECT OF SULFONYLUREA ON TISSUE SENSITIVITY TO INSULIN IN DIABETES MELLITUS

It is possible that in patients with persistent fasting hyperglycemia, sulfonylureas may increase peripheral tissue insulin sensitivity resulting in improved tolerance and a reduction in fasting and postprandial glucose. With the development of techniques to specifically assess tissue glucose disposal, this question can be addressed. Dr. Cefalu's study is evaluating the effects of a second-generation sulfonylurea versus placebo in altering peripheral tissue insulin resistance in non-insulin dependent diabetes.